Integration of Glycolysis with the Epithelial-Mesenchymal Transition

PROJECT SUMMARY Overexpression of Zinc finger E-box binding homeobox 1 (ZEB1) in tumor cells promotes the epithelial- mesenchymal transition (EMT) that is associated with enhanced invasive and metastatic capabilities and the acquisition of cancer-stem cell characteristics. Understanding how ZEB1 is regulated should permit the identification of druggable targets that can be exploited for the treatment of metastatic cancers that over- express ZEB1, including pancreatic and non-small cell lung cancers (NSCLC). The HIF-1α-inducible 6- phosphofructo-2-kinase/fructose-2,6-bisphosphase-3 (PFKFB3) is over-expressed in tumors, activates glycolysis via its product fructose-2,6-bisphosphate and was recently found to be an activator of cyclin- dependent kinases (Cdks). Given the accumulating evidence suggesting a role for cell cycle regulators such as the Cdks in the EMT, we postulated that PFKFB3 may be essential for the acquisition/maintenance of mesenchymal traits in tumor cells. In preliminary studies, we demonstrate that PFKFB3 silencing in A549 NSCLC cells and MIA PaCa-2 pancreatic cancer cells causes a marked decrease in ZEB1 expression and reverses the EMT, as assessed by increased E-cadherin (an epithelial marker) and decreased vimentin/fibronectin (mesenchymal markers) levels. We further show that knockdown of PFKFB3 decreases the phosphorylation of the retinoblastoma (RB) protein, a Cdk target, and the expression of the STAT3 protein, both of which have recently been found to regulate ZEB1 expression. We therefore hypothesize that upregulation of PFKFB3 in tumor cells increases ZEB1 expression via an RB and/or STAT3-dependent mechanism, leading to the acquisition/maintenance of a mesenchymal phenotype associated with increased metastatic ability and stemness. The following specific aims will be pursued to test this hypothesis: (1) To study the functional interaction of PFKFB3 with ZEB1 and its effect on invasion and cancer stem cell properties in vitro; and (2) To examine the functional interaction of PFKFB3 with ZEB1 in the progression of metastatic pancreatic adenocarcinoma in vivo. At the end of these studies, we expect to have established a novel function for PFKFB3 in the regulation of the ZEB1 gene and EMT, which may have therapeutic implications for the treatment of aggressive, metastatic cancers such as pancreatic adenocarcinoma.

Public health relevance
PROJECT NARRATIVE We are proposing to determine the role of PFKFB3 in the regulation of the metastasis-causing ZEB1 protein in order to develop better approaches to treat metastatic cancers marked by elevated ZEB1 protein levels. Importantly, if PFKFB3 is found to regulate ZEB1 and to be required for metastatic potential, then trials will be designed to specifically test the ability of the PFKFB3 inhibitor, PFK158, to suppress the development of metastases in patients who have resected cancers or limited metastases. __SpecificAimsTextDelimiter__ SPECIFIC AIMS - Integrating Glycolysis with the Epithelial-Mesenchymal Transition Cancer-related deaths are predominantly due to the metastatic spread of neoplastic cells which subsequently disrupt vital organ vasculature and functions. Emerging evidence suggests the epithelial-mesenchymal transition (EMT) is a driver towards a molecular signature that endows neoplastic cells with the ability to invade, metastasize and become secondary tumors [1-4]. Zinc finger E-box binding homeobox 1 (ZEB1) is a key transcriptional repressor involved in epithelial plasticity during embryonic development [5, 6]. Re- expression of the ZEB1 protein in tumor cells induces the EMT that is associated with enhanced invasive and metastatic capabilities [7-10] and acquisition of cancer stem cell properties [11-13]. ZEB1 expression has also been implicated in conferring resistance to Ras-directed therapies in highly malignant pancreatic and lung cancer cell lines that carry mutated KRAS genes [13, 14]. Although ZEB1 is an attractive target for drug development, agents that selectively disrupt transcription factor functions are difficult to identify and have not proven useful in the clinic. Accordingly, the identification of druggable targets that regulate ZEB1 expression may enable the design of novel therapeutic approaches to inhibit the metastatic spread of neoplastic cells that over-express ZEB1. The HIF-1α-inducible 6-phosphofructo-2-kinase/fructose 2,6-bisphosphatase-3 (PFKFB3) catalyzes the conversion of the glycolytic intermediate fructose 6-phosphate (Fru-6-P) to fructose 2,6-bisphosphate (Fru-2,6-P2) [15, 16]. Fru-2,6-P2 is recognized as the most potent allosteric activator of 6-phosphofructo-1-kinase (PFK1) [16, 17], which catalyzes a rate-limiting step of glycolysis [17]. Studies have shown that PFKFB3 is (1) highly expressed in tumors [15, 18]; (2) essential in oncogenic transformation driven by RAS [19] and loss of PTEN [20]; and (3) required for tumor growth in various xenograft models [21, 22]. Furthermore, we have recently demonstrated that PFKFB3 increases the activity of cyclin-dependent kinases (CDKs) [23]. Importantly, deregulation of CDK activity in tumor cells is known to induce ZEB1 expression, leading to the EMT and expression of cancer stem cell markers [8, 9, 24]. Taken together, these studies suggest that PFKFB3 may play a crucial role in the acquisition of a mesenchymal phenotype and increased metastatic ability. Analysis of transcriptomic data sets from Oncomine revealed that PFKFB3 expression highly correlates with ZEB1 expression. In preliminary studies, we have found that: (1) silencing of PFKFB3 decreases ZEB1 expression and promotes a molecular phenotype consistent with the reversal of EMT (i.e. MET) in A549 and MIA PaCa-2 cells ; (2) PFKFB3 is required for the invasive ability of A549 and MIA PaCa-2 cells; and (3) silencing of PFKFB3 in A549 and MIA PaCa-2 cells markedly decreases the phosphorylation of the retinoblastoma (RB) protein, a CDK target, and the expression of the STAT3 protein, both of which have recently been found to regulate the expression of the ZEB1 gene [8, 9, 25, 26]. The central hypothesis of this application is that upregulation of PFKFB3 integrates glycolysis with the EMT by increasing ZEB1 expression via an RB and/or STAT3-dependent mechanism, leading to the acquisition of a mesenchymal phenotype associated with increased metastatic ability and stemness. We will test this hypothesis by conducting the following specific aims: Aim 1. To study the functional interaction of PFKFB3 with ZEB1 and its effect on invasion and cancer stem cell properties in vitro. Aim 2. To examine the functional interaction of PFKFB3 with ZEB1 in the progression of metastatic pancreatic adenocarcinoma in vivo. A clinical grade inhibitor of PFKFB3 developed in our lab, PFK158, (Advanced Cancer Therapeutics, LLC) will be tested in a phase I clinical trial in advanced solid tumor patients starting in November 2013. Therefore, confirmation of a novel function for PFKFB3 in the regulation of the ZEB1 gene may promptly lead to the testing of PFK158 as an adjuvant to surgery as well as part of an active treatment regimen to prevent/treat metastatic cancers characterized by high ZEB1 expression.